Outer Membrane Vesicles in Shiga Toxin-Mediated Inflammatory and Thrombotic Responses Leading to Systemic Disease

Enterohemorrhagic E. coli (EHEC) serotype O157:H7 is a foodborne diarrheal illness typically transmitted by
contaminated beef or produce, resulting in bloody diarrhea. EHEC produce Shiga toxin (Stx), a protein
synthesis inhibitor that when absorbed from the intestine into the bloodstream, can lead to the devastating
illness, hemolytic uremic syndrome (HUS). HUS is characterized by fibrin-platelet thrombi in the
microvasculature and inflammatory damage of affected organs such as the kidney, resulting in renal failure.
Systemic exposure to LPS or other PAMPs during the diarrheal phase of infection can potentiate Stx’s
deleterious effects and is thought to be important in pathogenesis. EHEC are not invasive, so Stx must
traverse the intestinal epithelium to enter the systemic circulation. However, free Stx is not commonly found in
patients with HUS, and we lack an understanding of how and in what form Stx enters the blood and eventually
reaches the kidney. One potential under-explored mechanism is via uptake in the form of Stx-containing outer
membrane vesicles (OMV’s), EHEC-derived microparticles that can be absorbed from the intestinal lumen into
the bloodstream and contain, in addition to Stx, a plethora of PAMPs such as LPS and flagellae, as well as
other EHEC-encoded toxins. In this proposal, we will assess how outer membrane vesicles (OMV’s) interact
with cells of renal origin in the presence of absence of macrophages, inflammatory cells that infiltrate the
kidney in animal models of HUS. Because OMV’s are endocytosed, LPS sensing occurs intracellularly rather
than via TLR4, thus we expect to observe responses that are fundamentally different from those occurring
when Stx and LPS are co-delivered exogenously. The ability to generate OMV from EHEC mutants with
altered LPS (or other PAMPs or toxins) provide the opportunity to identify key features leading to damaging
cellular responses. In addition, it has been hypothesized that a key event in HUS pathogenesis occurs when
Stx engages circulating blood cells, resulting in the formation of Stx-containing, prothrombotic microvesicles
that then intoxicate distal organs. During EHEC infection, blood components may encounter Stx, LPS, and
other potentially damaging bacterially derived virulence factors in the context of OMV’s, but little is known
about OMV-mediated microvesicle production. We will compare the quantity of microvesicles produced upon
exposure of blood cells to purified Stx or Stx-containing OMVs from wild type EHEC or EHEC deficient in
PAMPs or virulence factors. OMV-associated cargoes, particularly the prothrombotic/pro-coagulant molecules
will be characterized, and for their effect on the renal cells described above. These in vitro studies lay the
critical groundwork for future in vivo studies in an animal model of EHEC infection. A fundamental
understanding of how and in what form Stx is encountered by the host, as well as how cellular responses are
influenced by the mode of Stx delivery, may inform new therapeutic modalities to prevent HUS.

Public health relevance
Enterohemorrhagic E. coli (EHEC) causes ~265,000 cases of human intestinal and systemic illness in the U.S. annually, but there are no specific treatments for the deadly kidney disease caused by spread of a toxin from the gut to the bloodstream. We are studying how the toxin may move around the body in tiny sacs that 1) contain other substances that enhance the toxin’s effects on kidney cells, and 2) can hide the toxin hide from antibody treatments. Our long-term goal is to use knowledge gained to develop treatments to prevent potentially the fatal kidney disease resulting from EHEC infection.